Reducing Sedentary Time Using an Innovative mHealth Intervention Among Total Knee Replacement Patients

Project Summary/Abstract
The number of individuals undergoing total knee replacement (TKR) each year continues to rise. While
TKR is effective for improving pain and function, subsequent improvements in physical activity are not
common. As a result, patients spend most of their day engaged in sedentary behavior, which may put them at
higher risk of experiencing poor function and disability, as well as lower the overall success of the surgical
treatment. Intervening on sedentary time, rather than physical activity, may be a more feasible first-step
approach for modifying activity-related behaviors in this population. Therefore, the purpose of this innovative
clinical trial is to use TKR as a teachable moment for implementing a sedentary reduction intervention.
We propose to use a just-in-time mobile health (mHealth) intervention to reduce sedentary time among
TKR patients. Patients (n=92) scheduled for TKR will be recruited to participate prior to surgery and then
randomized at 4 weeks after surgery to either (1) NEAT!2 or (2) Control. NEAT!2 participants will use the
NEAT!2 (Non-Exercise Activity Thermogenesis version 2) smartphone app until 3 months after surgery. The
NEAT!2 app is designed to provide a vibration and/or audible tone to interrupt prolonged bouts of sitting
detected from the smartphone’s internal accelerometer. Further, NEAT!2 has been adapted based on TKA
patient input and program preference. NEAT!2 participants will receive biweekly coaching calls between 4 and
12 weeks after surgery. Control participants will receive an education control app and receive non-intervention
calls to assess general recovery. Both groups will receive monthly maintenance calls between 3 and 6
months. Data collection will occur pre-operatively, as well as at the end of treatment (3 months after TKR) and
the maintenance assessment (6 months after TKR). The primary aim is to examine the effects of the NEAT!2
intervention on sedentary time at end of treatment (3 months) and maintenance (6 months). Secondary aims
include examining the effects of the NEAT!2 intervention on physical function, physical activity, and pain as
well as examining the dose response relationship between adherence to NEAT!2 and changes in outcomes.
The proposed study will examine the innovative approach of decreasing sedentary time prior to
targeting physical activity in adults after TKR and determine if a remotely-delivered, mHealth sedentary
reduction intervention can decrease sedentary time. The study is innovative for integrating a just-in-time
technology-based approach to reduce sedentary time during a “teachable moment” for TKR patients. The
results of this study will build on our previous and current work to improve health behaviors after TKA and help
to identify potentially effective and scalable strategies to improve long-term physical activity behaviors and
physical function in patients after TKR.

Public health relevance
The proposed project is relevant to public health because of the increased utilization of total knee replacement and subsequent level of inactivity following the surgery, jeopardizing the long-term success of the treatment. This proposal takes the innovative approach of targeting a reduction in sedentary time prior to emphasizing an increase in physical activity, which may prove to be beneficial for knee replacement patients and long-term functional outcomes. Specifically, this project aims to examine the effects of a novel mobile health intervention on sedentary time, physical function, activity, and pain in patients after total knee replacement.